Cognitive Reappraisal for Mitigating Incubation of Cocaine Cue-Reactivity

SUMMARY
Cocaine use is endemic nationwide. According to a national survey, over 2.5% of the population of individuals
12 years and older reported crack or cocaine use in the past year, accounting for over 10,000 deaths related to
cocaine overdose. Recent data suggests that the COVID-19 pandemic has exacerbated substance use in the
United States. Only a small minority of cocaine users seek formal treatment for their addiction, and even in those
who do, the relapse rate remains disturbingly high with some studies reporting rates as high as 90%, 12 months
after treatment. Relapse in addicted individuals is presumed to precipitate from the re-exposure to cues that
were previously associated with drug use. Over the course of chronic drug use, these cues are afforded
enhanced attention (or attention-bias), which has shown to promote motivated arousal, culminating in compulsive
drug-seeking or relapse. We have used the late positive potential (LPP), an EEG-derived marker of motivated
arousal to show that, unlike commonly believed, arousal to drug cues (or cue-reactivity) increases (or incubates)
during the first six months of abstinence. Such incubation of cue-reactivity is posited to confer disproportionately
high relapse vulnerability in addicted individuals. Our recently acquired follow-up data show that addicted
individuals are able to down-regulate drug cue-reactivity (as evident via a decrease in LPP amplitude) via
cognitive reappraisal (an emotion-regulation technique) training, which then leads to a reduction in spontaneous
attention-bias to drug cues (quantified using eye-tracking). Here, we propose to integrate the two pieces of
evidence to test whether cognitive reappraisal training can reduce the incubation of drug cue-reactivity (Aim 1)
and improve clinical outcomes (e.g., reduce craving and prolong cocaine abstinence duration; Aim 2) during the
first 6 months of abstinence in individuals with cocaine use disorder (iCUD). We will further explore whether
changes in attention-bias to drug cues and/or blunting of incubation of cue-reactivity tracks treatment response
and predicts clinical outcomes at 6 months follow-up (exploratory aim). For this purpose, we propose to enroll
126 iCUD, half of whom will be randomized to undergo cognitive reappraisal training and the other half will
instead complete a control task. In this longitudinal study, participants will complete these procedures at 1-week,
1-, 3-, and 5-months post abstinence initiation, and will then come back one month after (at 6 months post
abstinence initiation) for the assessment of clinical outcomes. Thus, this novel study aims to bridge between the
lab and the clinic by advancing basic mechanistic understanding of a novel evidence-based intervention to
provide cognitive markers for tracking treatment response and predicting outcomes in addiction. Successful
completion of this study would lay the foundation for further basic and clinical studies that will examine other
putative mechanisms and potentially also use the same framework for the neurocognitive examination of similar
cognitive interventions in other substance use disorders as well as in other behavioral addictions.

Public health relevance
PROJECT NARRATIVE Substance use has been declared as a public health emergency, fueled by alarmingly high relapse rate (as high as 90%). This mechanistic human study will examine whether down-regulation of enhanced preferential attention to drug-related cues to reduce craving and prolong abstinence in individuals with cocaine use disorder. Successful completion of this project will advance mechanistic research into developing attention regulation as a potential behavioral intervention for relapse prevention in substance use disorders.